Genetic Characterization of Canine Brain Tumors

Previously, histological reassessment was conducted on 116 meningioma samples representing 10 histological types: Grade 1 (Meningothelial, transitional, fibrous, angiomatous, psammomatous, syncytial, microcystic), Grade 2 (Chordoid, atypical), and Grade 3 (anaplastic). Whole-genome bisulfide sequencing and bioinformatic analysis was completed and 3 DNA methylation groups were found. Group 1 included inflammatory, immune, and IL-2 signaling pathways, Group 2 exhibited FOXM1 and cell cycle targets, and Group 3 revealed enrichment of Hedgehog target genes.

This year, RNA-Seq data analysis was completed for 116 meningioma samples. Differentially expressed genes were identified across each meningioma grade. A core group of genes—HOXA2, BPIFA1, HOXA13, PI3, HOXB3, HOXA3, and BPIFP1—were consistently upregulated across all tumor grades. In contrast, SLC6A20, SLC22A2, SERPIND1, ALDH1A1, and CACNG3 were commonly downregulated across most grades.
Notable grade-specific expression patterns included:

Grade 1: Downregulated genes such as TBX5 and HAND1; upregulated genes including KRT35 and DLGAP5.
Grade 2: Downregulated genes such as OPRK1 and LAMP5; upregulated genes including PENK and EHF.
Grade 3: Downregulated genes such as TTR and CALB1; upregulated genes including TBX5 and HOXA11.

Pathway analysis of these gene sets is currently underway.